Chemistry Food Defense Track

PROJECT SUMMARY / ABSTRACT The Minnesota Department of Agriculture (MDA) Laboratory Services Division (LSD) is seeking funding under FDA funding opportunity PAR-20-105, “Laboratory Flexible Funding Model (U19)”. This summary is for the Chemistry Discipline Analytical Track 1: Food Defense. The purpose of this track is to ensure laboratory surge capacity for the analysis of foods and food products related to chemical contamination, through intentional means. As part of this analytical track the MDA laboratory commits to analyzing at least 75 food samples for food defense agents. Project Summary/Abstract - Minnesota Department of Agriculture